THREE-DIMENSIONAL STRUCTURE OF HHAI METHYLASE

DNA methyltransferases are found in organisms ranging from bacteriophages to mammals. The function of methylases include protection of DNA against restriction enzymes as well as DNA mismatch repair in prokaryotes, and the control of gene expression, epigenesis, and genomic imprinting in eukaryotes. The long-term goal of this proposal is to understand from a structural standpoint how DNA-(cytosine-5)-methylases work with special emphasis on the mechanism of protein-DNA interactions. One such enzyme, M.HhaI methylase will be the focus of this study. The crystals of M.HhaI are the first useful crystals of a 5-cytosine methyltransferase. The three-dimensional structure(s) of M.HhaI in the presence of its cofactor AdoMet, the complex of M.HhaI with DNA, the covalent complex of M.HhaI with an oligonucleotide containing 5- fluorocytosine, and the complex between DNA and a mutant M.HhaI that binds to DNA tightly but is unable to methylate will be determined by the methods of X-ray crystallography. The structural information will enable the understanding of how M.HhaI recognizes a specific DNA sequence, and how it catalyses the methylation reaction. Due to the conserved nature of cytosine methylases, the implications of our knowledge on M.HhaI can be generalized to the entire family including the mammalian CpG methyltransferase. More significantly, the structural knowledge of specific DNA binding may enable us to design new methylases with altered specificities, which would be extremely useful tools for molecular biology and possibly for the human genome project.